HABS-HD - Core B - Neuroimaging & Informatics Core

HABS-HD Neuroimaging & Informatics Core (Core B) Abstract
The Neuroimaging & Informatics Core (Core B) is responsible for all neuroimaging acquisition protocols,
storage protocols, QA/QC protocols, processing pipelines, and long-term storage of raw scans for the Health
and Aging Brain Study- Health Disparities (HABS-HD) U19. The overall objective of Core B is to provide high
quality imaging and summary data for Projects 1, 2, and 3 and for all U19 investigators. Core B is led by Dr.
Arthur Toga (USC/LONI) and Co-Led by Dr. Meredith Braskie (USC/LONI/IGC). Images obtained as part of
HABS-HD are stored and managed within the Laboratory of Neuro Imaging (LONI). At initiation of the HABS-
HD U19, approximately 5,000 MRI scans and 6,000 PET scans will have been collected, stored and processed.
HABS-HD magnetic resonance imaging (MRI) and amyloid positron emission tomography (PET) acquisition
largely aligns to standard ADNI3 protocols. Selected imaging modalities will be processed by Core B and
summary data will be uploaded to the HABS-HD database at 6-month intervals. All raw scans will also be
available. Core B will provide the amyloid (A), tau (T), neurodegeneration (N), for the AT(N) framework that
will be leveraged by Projects 1, 2 and 3, and will also provide summary vascular imaging data to be used by
Project 2. All neuroimaging for the HABS-HD program occurs at the University of North Texas Health Science
Center Institute for Translational Research (UNTHSC ITR) Imaging Center using the same MRI and PET
scanners. Core strengths include decades of experience developing and managing multisite, large data
projects. Under the leadership of Drs. Toga and Braskie and using the infrastructure of the USC Institute for
Neuroimaging and Informatics (INI), LONI and ATRI, we will provide multi-site data management and
dissemination of imaging and clinical data in a manner consistent with systems supporting the Alzheimer
Disease Neuroimaging Initiative (ADNI), Global Alzheimer’s Association Interactive Network (GAAIN),
Parkinson Progression Marker Initiative (PPMI), and others. All Core B activities will support the U19 scientific
goals and the broader national AD and dementia research community. This first-ever comprehensive multimodal
study of AD risk using the AT(N) framework within the three largest racial/ethnic groups in the U.S. (75% of the
population) requires robust informatics, data management, and harmonization. Core B Aims are as follows: Aim
1: To create an imaging and informatics data management framework for all U19 Projects. Aim 2: To ensure
high quality control of all neuroimaging data. Aim 3: To deliver a harmonized analysis workflow for each imaging
modality that can accommodate any computational environment.